INTRON A THERAPY FOR TREATMENT OF RELAPSE IN PATIENTS WITH CHRONIC HEPATITIS C

To evaluate the effectiveness and safety of long-term continuous Intron A therapy vs repeated 24-week course as needed for relapse in maintaining lasting remission in patients with chronic hepatitis C.